Synthetic Biology Approaches to Engineer Lactococcus lactis for Targeted Delivery of Therapeutic Lasso Peptides

ABSTRACT:
Emerging strategies in synthetic biology present exciting opportunities for utilizing genetically engineered
bacteria as drug delivery vehicles, offering new solutions and possibilities for drug development within the
framework of precision medicine. However, there remains a gap in our knowledge regarding the development
of platforms that can harness synthetic bacteria to directly synthesize and target natural product-based drugs.
To address this gap, we aim to engineer a platform using genetically modified Lactococcus lactis capable of
expressing biosynthetic gene clusters encoding bioactive natural products, enabling in situ drug production
and targeted delivery to specific tissues. Our approach involves leveraging synthetic biology techniques to
rewire the metabolic pathways of this engineered bacterium, enabling the production and release of bioactive
natural products, specifically lasso peptides. This innovative proposal not only advances research in this field
but also provides undergraduate students with the opportunity to develop experimental skills and foster
creative thinking. We will begin by focusing on the biosynthesis of BI-32169, a compound known for its anti-
diabetic and weight-control properties, by reconstructing its biosynthetic gene cluster in L. lactis. Through
rational gene editing, we will modify key enzymes in the biosynthetic pathway of BI-32169 and, using
structure-activity relationship (SAR)-based approaches, generate a library of bioactive analogs (BIs). These
compounds will then undergo in vitro screening to identify the most potent candidates. Subsequently, we will
design gene circuits to control the lysis of L. lactis within the gut environment, enabling the targeted release
of these bioactive natural products. By carefully engineering these circuits, we will regulate the synthesis and
release rates of the compounds to control drug concentrations. Next, we will employ an in vitro gut model to
test the efficacy of the lysis circuits in releasing the bioactive compounds, optimizing the engineered bacteria
for therapeutic use. Finally, we will validate the anti-diabetic efficacy of the engineered bacteria through in
vivo studies in animal models. The long-term goal of this project is to establish a precise in vivo delivery
system for bioactive natural products using L. lactis, while also contributing to the education of future synthetic
biology talent in economically transitioning regions of the Midwest.

Public health relevance
PROJECT NARRATIVE: The use of bacteria as vehicles for drug delivery is a revolutionary novel approach for therapeutic purposes. The current proposal aims to develop a bacteria-based system for the targeted delivery of active natural products using engineered Lactococcus lactis as the platform to express biosynthetic gene clusters encoding active compounds for in situ production and delivery.